Pediatric Fungal Network's (PFN) STudy of Rare Invasive Fungal DisEases in Immunocompromised Pediatric Patients (STRIDE) Project 3

PROJECT 3 SUMMARY/ABSTRACT
Invasive fungal disease (IFD) is a significant cause of morbidity and mortality in immunocompromised pediatric
patients. Early and accurate diagnosis is crucial for improving outcomes, but current diagnostic methods have
limitations. Project 3 of this this Pediatric Fungal Network STudy of Rare Invasive Fungal DisEases in
Immunocompromised Pediatric Patients (PFN-STRIDE) Rare Diseases Clinical Research Consortium (RDCRC)
aims to develop and validate novel, non-invasive approaches for diagnosing IFDs in pediatric patients by utilizing
host response signatures and artificial intelligence (AI)-driven imaging analysis. Both aims will be accomplished
using cohorts assembled from a prior NIH funded PFN study called DOMINIC (Non-Invasive Diagnosis Of
Pulmonary Mold INfections in Immunocompromised Children) and from Project 1 of PFN-STRIDE.
The first aim of Project 3 will develop and validate host transcriptomic signatures of IFD from banked and
prospectively collected whole blood samples of at-risk immunocompromised children enrolled at participating
PFN sites. Using bulk RNA sequencing and machine learning approaches, we will generate signatures that can
accurately distinguish IFD from other clinical syndromes. The second aim will leverage AI-driven imaging
analysis to automate detection of radiographic features consistent with pulmonary IFD in immunocompromised
pediatric patients. We will develop prediction models using chest CT scans from the NIH funded PFN study
DOMINIC, aiming to distinguish radiographic IFD features from other infectious or non-infectious processes.
These models will be validated using images from prospectively enrolled patients on PFN-STRIDE.
This project offers several innovative aspects, including: 1) the first large-scale study of host
transcriptional biomarkers for IFD diagnosis in pediatric patients; 2) the development of AI tools for interpreting
CT imaging in pediatric pulmonary IFD; and 3) the creation of a unique IFD biobank and imaging repository
linked to detailed microbiologic and clinical data. Successful completion of this project will result in development
of novel IFD diagnostic tools that can be assessed in future studies of immunocompromised pediatric patients,
potentially improving time to diagnosis. The established biobank and imaging repository will serve as valuable
resources for future IFD research. This work aligns with strategic priorities determined by international groups
and consortia, addressing critical knowledge gaps in pediatric IFD diagnosis.